BCM/RICE GENOME EDITING TESTING CENTER

1. ABSTRACT – OVERALL
Somatic cell genome editing holds tremendous promise as a potential cure for the most severe of human
diseases. However, many new technologies do not progress into humans because of insufficient preclinical data
in animal models. Mice are particularly important early in the preclinical development pipeline because of their
genetic tractability and similarities to humans in development, physiology, metabolism and disease. Fluorescent
reporter mice are a powerful tool for assessing genome editing efficacy across multiple organ systems and make
it possible to quantify editing events down to single cell resolution. Mouse disease models harboring pathogenic
mutations can be used to determine the nature of on- and off-target editing events that may occur, the safety of
a genome editing approach, and the genome editing threshold required for disease amelioration. Solving the
challenges of somatic genome editing is a formidable interdisciplinary effort requiring diverse expertise ranging
from molecular biology and bioengineering to pathology and immunology. Thus, it is critical to have resources
for animal model testing that can bring these components together in one place. We will leverage the expertise
and resources of our existing large-scale, NIH-funded projects centered around mouse modeling, including our
current BCM-Rice Small Animal Testing Center (SATC) of the Somatic Cell Genome Editing (SCGE) program,
to form the BCM/Rice Genome Editing Testing Center (GETC). The vision of the GETC is to offer high-quality
mouse resources and robust somatic genome editing testing pipelines that can support researchers developing
new genome editing technologies and conducting preclinical tests with these novel tools. Our goal is to use wild-
type, genome editing reporter, and human disease model mouse lines to evaluate (1) the efficacy, tissue
specificity, and safety of genome editing technologies and delivery systems and (2) disease gene editing
approaches and genome editing thresholds required to ameliorate specific diseases. By centralizing mouse
resources and testing fee-for-services within an environment harboring a supportive and experienced research
team, the GETC can ensure the highest experimental standards, rigor, and reproducibility. We expect the GETC
will make a broad and sustained impact by supporting the development of new genome editing technologies and
accelerating their effective and safe deployment to the clinic.

Public health relevance
Genome editing systems have the potential to cure some of the most severe human diseases. However, there are significant efficacy and safety issues that must be addressed before this technology can be applied in clinical trials. The BCM/Rice Genome Editing Testing Center will provide mouse resources and testing fee-for-services to the growing community developing new genome editing technologies and conducting preclinical testing based upon these technologies.